Real-time three-dimensional spinal navigation system for bedside lumbar puncture placement

PROJECT SUMMARY/ABSTRACT
Over 450,000 diagnostic lumbar punctures (LPs) are performed annually in the US, but up to 15 – 35% end
in procedural failure, primarily due to inability to access the intrathecal space. Bedside LP failure rates are
particularly high in the growing obese population, with recent studies reporting failure rates greater than 50% in
subjects over BMI 35 kg/m2. Given its technical difficulty, there is a reluctance to perform bedside LPs, even
when medically indicated. Consequently, 30 – 50% of LPs are now performed under fluoroscopic guidance, but
securing neuroradiology services delays diagnosis, adds cost, and is not possible in emergency or critical care
situations. The total direct and indirect costs of failed LPs to patients and the healthcare system exceed
$500M/yr. Thus, there is a clear need for bedside LPs to reach success rates similar to those performed using
fluoroscopy, and it is likely that a technological advancement that reduces the difficulty of administering LPs is
required to meet this need.
During this project, a 3D ultrasound-based bedside LP guidance system will be developed under a quality
management system (QMS) certified to ISO 13485:2016 and 21 CFR Part 820. The key technological
innovations underpinning the development of this product include the following: 3D bone reconstruction
technologies enabling ‘fluoroscopy-like’ renderings of the lumbar spine, spine landmark recognition algorithms
that automatically detect the location of the intrathecal space, and needle guidance methods to aid
visualization of the needle trajectory. The primary technical tasks during the early phases of the project period
include the execution of end-user clinical usability studies to guide technical specification development, electro-
mechanical sub-system design, integration, and validation, and design and implementation of core ultrasound
imaging processing and visualization algorithms. Successful completion of these technical aims will result in
fabrication of pre-production systems for pre-clinical validation studies later in the project period.
Pre-clinical product validation activities will include cadaver and human-imaging studies performed in
collaboration with clinical experts who will validate that the system meets the requirements for the clinical
application. The primary endpoint for the pre-clinical cadaveric studies is a direct comparison of needle
placement accuracy between the current standard of care (blind needle placement) and the 3D-ultrasound
needle guidance product. An additional pre-clinical study will characterize overall system usability and the
learning curve required to reach competency with the system by studying the product’s use in 150 simulated
imaging procedures, performed by at least 10 individual neurologists.
Completion of this research project will result in the development and fabrication of a human clinical-trial-
ready 3D-imaging based lumbar puncture guidance system.

Public health relevance
PROJECT NARRATIVE Lumbar puncture performed at the patient bedside is the mainstay for cerebrospinal fluid sampling during the diagnosis and management of many inflammatory and degenerative neurological disorders. Procedural failures occur in approximately 15 – 35 % of all cases, and in over 50 % of lumbar punctures performed in obese subjects, due to the inability to access the subarachnoid space during needle placement – a problem that results in delayed treatment and diagnosis, increased risk of associated complications, and additional costs to the patient and healthcare system. The goal of this project is to evaluate the efficacy of an ultrasound-based bedside lumbar puncture guidance system that facilitates real-time needle guidance, improves procedural success rates, and lowers the risk of complications.